Extending a Risk-taking Model of Alcohol-facilitated Consensual and Sexually Coercive Hook-up Behaviors Using a Daily Diary Design among College Men

Project Summary/Abstract The purpose of this application is to request administrative supplements to support childcare costs for the NRSA-supported fellow, Alisa Garner. The fellow is requesting $7,500 in childcare costs over the remaining 29 months (2 years and 5 months) of her fellowship. The childcare will be for the fellow’s dependent child living in her home, who is under the age of 13, and will be provided by a licensed childcare provider. The fellow is requesting $2,500 for 12 months for the first budget period, $2,500 for 12 months for the second budget period, and $2,500 for 5 months for the third budget period.

Public health relevance
Placeholder There are no changes from the original submission.